The Role of CHD7 in ACC neurons

A limited fundamental understanding of the cellular and molecular mechanisms underlying complex behaviors
poses a major barrier for development of effective clinical applications to treat mental disorders. The long-term
goal of our research is to shed light on the gaps in knowledge regarding the molecular signatures and synaptic
properties of brain neuronal circuits that control responses to stress. Epigenetic gene regulation has emerged
as a key molecular driver underlying neuronal circuit dynamics and behavioral changes. Our preliminary data
suggest that CHD7, a chromatin-remodeling factor primarily expressed in the embryonic brain, remains enriched
in excitatory neurons within layer 2/3 of the anterior cingulate cortex (ACC) in adult mice. The ACC, a region
within the medial prefrontal cortex in rodents, plays critical roles in processing mood-related information and
modulating anxiety-related behaviors. While critical roles for CHD7 during neural development have been well-
documented, its function in postmitotic neurons remains unclear. Our data suggest that postmitotic deletion of
Chd7 from ACC excitatory neurons (referred to as Chd7cKO) significantly reduced innate anxiety levels. In
addition, neuronal activity in the ACC of Chd7cKO mice exposed to an environmental stressor was significantly
lower than that in wild type (WT) mice. Intriguingly, these phenomena were observed only in male (and not
female) mice, indicating sexual dimorphism of CHD7 function. Our data provide the first evidence suggesting an
essential role for CHD7 in postmitotic ACC neurons in regulating neuronal activity and innate anxiety. Our primary
objectives are to interrogate the role of CHD7 in controlling a complex gene network to regulate the synaptic
activity of ACC neurons and their downstream targets. In this proposal, we will first determine how CHD7
regulates the activity of ACC neurons and their downstream targets in the bed nucleus of the stria terminalis
(BNST). Our preliminary data suggest that CHD7 plays a critical role in maintaining proper neuronal activity in
the ACC-BNST pathway. Next, we will use unbiased high-throughput approaches to determine how CHD7
controls a complex gene network in postmitotic neurons to regulate activity-dependent gene transcription. Finally,
we will investigate how CHD7 activity is regulated by an interacting partner that is involved in G protein signaling.
If successful, our research will shed new light on the molecular underpinnings and neurophysiology of neuronal
circuits that respond to stress. Such information will ultimately help define mechanisms underlying complex
emotional behaviors in humans.

Public health relevance
The limited fundamental understanding of cellular and molecular mechanisms underlying complex behaviors poses a major barrier for development of effective clinical applications to treat mental disorders. If successful, our research will significantly advance our fundamental understanding of epigenetic regulation of neuronal circuits controlling stress responses, and ultimately help pave the way for improving mental health in humans.